The CFAR Diversity, Equity, and Inclusion Pathway Initiative to Support The Continued Development of Generation Tomorrow (JHU CFAR Supplement)

Project Summary
This is a competing revision for the Johns Hopkins University (JHU) CFAR to permit continued support for our
Diversity, Equity and Inclusion Pathway Initiative (CDEIPI) program, originally funded as a CFAR supplement.
The program leverages the strengths of the JHU CFAR and is in line with the overall CFAR goals with a
specific focus on providing mentoring, support, and pilot funding for the next generation of HIV/AIDS
researchers, and to increase the pipeline of new investigators from groups underrepresented in medicine and
health. This application will primarily support the Generation Tomorrow: Summer Health Disparity Scholars
(GT:SHDS) program which began in 2019 as an expansion of Generation Tomorrow (established in 2013).
The GT:SHDS was initially launched as a 10-week summer program for undergraduate students from across
the United States interested in HIV and/or HCV health disparities and their intersection with substance use
(addiction and overdose), violence, mental health, and the social determinants of health. With CDEIPI FY21-23
funds, the program expanded to include a graduate student training track. The program offers mentorship and
training in HIV/HCV education, testing, and counseling; health disparities, cultural competence, and harm
reduction. The participants also engage in community outreach with community partner, Sisters Together and
Reaching, Inc. The program has a special focus on students that are underrepresented in nursing, public
health, medicine, and science with an emphasis on first generation college students and individuals from
minoritized/disadvantaged backgrounds. The purpose of this proposal is to sustain/grow GT:SHDS, therefore,
our specific aims are: Aim 1. To increase the volume in our pathway to assist individuals from disadvantaged
backgrounds in gaining exposure to mentorship and research in health careers/science professions with a
focus on HIV and HCV health disparities. Aim 2. To enhance cultural competence and humility by promoting
respect for the patient, their values/beliefs, and lived experiences. Aim 3. To promote comprehensive care of
individuals impacted by HIV and HCV infections with a recognition of the importance of the intersection with
substance use (addiction and overdose), violence, mental health, and the social determinants of health. Aim:
4.To support the professional identify formation (PIF) of developing healthcare professionals from diverse
backgrounds. In sum, the GT:SHDS program will support the CFAR goals to help to support a more diverse
and culturally competent HIV medical and scientific workforce which will in turn serve to reduce critical health
disparities with respect to HIV prevention and treatment outcomes.

Public health relevance
Project Narrative This application is being submitted for continued funding for Generation Tomorrow: Summer Health Disparity Scholars (GT:SHDS) as a part of the FY24 CFAR Diversity, Equity, and Inclusion Pathway Initiative (CDEIPI). GT:SHDS was launched under the leadership of Drs. Risha Irvin, Nathan Irvin, and Denis Antoine in 2019 and was designed to support and attract undergraduate students nationwide that are interested in HIV and/or hepatitis C virus (HCV) health disparities and their intersection with substance use, violence, mental health, and the social determinants of health. Through CDEIPI, the program has been expanded to include a graduate student training track.